Anaplasma Phagocytophilum Modulate Tick Gene Expression for its Survival and Transmission from the Vector Host

Project Summary/Abstract
In the United States, Ixodes scapularis ticks harbor and transmit several pathogens including
human anaplasmosis bacterial agent Anaplasma phagocytophilum. This bacterium is transmitted to the
vertebrate host by an infected tick bite. Several studies have addressed molecular mechanisms that A.
phagocytophilum uses to survive in the mammalian host. Relatively, few studies have clearly defined the
molecular strategies that this bacterium uses to survive in ticks. In the previous funding period, we
performed a comprehensive molecular analysis on I. scapularis organic anion transporting polypeptides
4056 (IsOATP4056) and genes involved in the tryptophan metabolism pathway in A. phagocytophilum-tick
interactions. We made substantial progress and have published several research articles showing
importance of IsOATP4056 and the tryptophan pathway in the survival and transmission of A.
phagocytophilum from ticks to the naïve vertebrate host. Passive Immunization with IsOATP4056
antibodies impaired A. phagocytophilum transmission from ticks to the vertebrate host. Anaplasma
phagocytophilum upregulates IsOATP4056 and activates the tryptophan pathway leading to the
increased synthesis of endogenous levels of tryptophan metabolite, Xanthurenic acid (XA). The
increased XA prevents the build-up of reactive oxygen species facilitating bacterial survival in tick cells. In
addition, A. phagocytophilum activates the XA-mediated p38-MAPK pathway to inhibit tick cell death
thereby facilitating the survival of both the bacterial agent and its vector host. We also reported a novel
role for XA in the transcriptional activation of isoatp4056 gene expression. Furthermore, A.
phagocytophilum downregulates microRNA (miR133) that targets isoatp4056 for its survival and
transmission from vector to the vertebrate host. These findings from our previous funding period
provide a strong rationale for the proposed aims for this R01 (competing renewal) application. In
Aim 1, we propose to understand the mechanism of how passive immunization affects the transmission of
A. phagocytophilum from ticks to the vertebrate host. In Aim 2, we will analyze whether targeting
IsOATP4056 via active immunization or OATP inhibitor treatment affects the transmission of A.
phagocytophilum from ticks to the vertebrate host. In Aim 3, we will characterize XA-mediated regulation
of miRNAs that are important in regulating gene expression during A. phagocytophilum survival and
transmission from infected ticks to the naïve host. Based on the success in the previous funding period
and the aims proposed in this renewal application, we believe that this could be a transformative study that
not only serves as a model to study intimate relationships established by pathogens with their arthropod
vectors but may also lead in the development of new strategies to interrupt the transmission of this and
perhaps other rickettsial bacteria of medical importance.

Public health relevance
Project Narrative The black-legged tick, Ixodes scapularis, transmit several pathogens, including Anaplasma phagocytophilum, the causative agent of human anaplasmosis. Survival in the vector in different developmental stages of ticks is particularly important for intracellular microbes, such as A. phagocytophilum, that cannot be transovarially transmitted. In this study, we propose to characterize the role of tick molecules such as organic anion transporting polypeptide (OATP), Xanthurenic acid (XA), tryptophan pathway and microRNAs in A. phagocytophilum survival and transmission from these medically important vectors.